Health Disparities Research Scholars Training Program-Renewal

PROJECT SUMMARY/ABSTRACT
Health disparities in the United States are large and historically rooted, begin early in life, and often persist
throughout the life course. The Health Disparities Research Scholars Program is an interdisciplinary postdoctoral
training program located in the Department of Population Health Sciences at the University of Wisconsin School
of Medicine and Public Health. It is designed to support the career development of health disparities researchers
and has two primary goals: 1) to develop a cadre of researchers who will work to advance knowledge of the
causes, consequences, and effective mitigation of disparities in health experienced by minority populations early
in and throughout the life course; and 2) to attract, retain, and support the development of a diverse set of health
disparities investigators as they embark on research careers dedicated to improving health equity. To achieve
these goals, we will actively recruit a diverse cadre of scholars who are committed to careers in health disparities
research and provide them with two or three years of training and support. We will recruit from doctorate
programs scholars who are ready to build on the methods of their graduate disciplines, cross boundaries, and
draw from content, theory, and methods of other fields. We have assembled an exceptional and diverse core
faculty with expertise across medical, population health, social/behavioral, and basic sciences. There are five
training components to the training program: i. a multidisciplinary mentor team; ii. a weekly Health Disparities
Research Scholars seminar and the opportunity to attend others on campus; iii. coursework, workshops, and
optional degree programs; iv. mentored research; and v. professional development activities. Through this
interdisciplinary training program, we will build key competencies and provide professional mentoring to facilitate
the success of our scholars as independent health disparities researchers. Scholar activities will be tracked
through quarterly progress reports, biannual mentor team meetings, and an annual formal evaluation of each
scholar. These assessments will enable the Program Director and mentor team to provide timely guidance and
identify strategies to ensure productivity and achievement of career goals.

Public health relevance
PROJECT NARRATIVE Health disparities in the United States are large, are historically rooted, and begin early in life. The Health Disparities Research Scholars program will train postdoctoral scholars to become interdisciplinary researchers who will advance knowledge of the causes of health disparities and of effective strategies to improve public health and health equity.